Development of an epigenetic clock that predicts age-impaired or age-unimpaired cognitive performance

Project Summary/Abstract
The ability to learn, consolidate and retrieve information begins to decline with normal aging, a major risk
factor for Alzheimer’s Disease (AD) and dementia. The 2012 National Projections report by the U.S. Census
Bureau indicates that in 2050 the population in the U.S. aged 65+ will be approximately 84 million, which will
reflect 21% of the predicted U.S. total population. Also in the U.S., 16-20% of current 65+ individuals are
predicted to be cognitively impaired. Understanding mechanisms of age-related cognitive decline may inform
AD-related dementia and lead to the discovery of effective treatments for improving cognitive function in AD.
Genomic and epigenomic studies, as well as cognitive neuroepigenetic studies, have demonstrated that
alterations of the epigenome may be critically important to age- and AD-associated cognitive decline. Recent
studies have also demonstrated that the epigenome, and DNA methylation in particular, may be used to
distinguish chronological age from biological age. That is, the exact age of an individual (chronological age)
versus the apparent age of an individual (biological age). The precise collection of patterns of DNA
methylation that are used to make these distinctions in different tissue types are called ‘epigenetic clocks’.
Although several epigenetic clocks have been published from mixed tissues and whole brain regions, there
are no studies identifying an epigenetic clock in a brain region necessary for memory, and determining the
ability of that clock to predict age-impaired or age-unimpaired cognitive performance, which would represent
a major conceptual and technical innovation. In this proposal, we aim to identify an epigenetic clock in the
hippocampus, a major brain region involved in learning and memory, and one that begins to decline with age
and becomes even further impaired with AD pathology. Our preliminary data demonstrates our ability to
develop a DNA methylation data analysis pipeline (using reduced representation bisulfite sequencing) from
the hippocampus of 2 and 20 month old male and female C57BL/6 mice, which established a foundation for
arriving at an epigenetic clock. In Aim 1 we proposed to identify a hippocampus epigenetic clock in wildtype
male and female mice across the lifespan, and to determine how that epigenetic clock is altered in the context
of AD using the 5xFAD mouse model. In Aim 2, we propose to determine the epigenetic clock can predict
age-impaired versus age-unimpaired cognitive performance in wild type animals, and whether the clock may
distinguish resilience versus susceptibility to cognitive decline in 5xFAD animals.

Public health relevance
Project Narrative Examination of genome-scale patterns in DNA methylation as a molecular indicator of tissue-specific aging has recently been explored in models that correlate epigenetic age with chronological age to form what are called “epigenetic clocks”. In this proposal, we aim to identify a hippocampus-specific epigenetic clock that distinguishes chronological age from biological age, which will also be capable of predicting age-impaired or age-unimpaired cognitive function in an individual. We also aim to understand the impact of Alzheimer’s Disease pathology on this hippocampus epigenetic clock to determine the ability of the clock to reveal aspects of resistance and vulnerability to cognitive decline in AD.